Phase 2 Study of Interferon-Gamma and Donor Lymphocyte Infusion for the Treatment of Relapsed Myeloid Malignancies after Allogeneic Stem Cell Transplantation

Project Summary/Abstract
Allogeneic stem cell transplantation (alloSCT) is a potentially curative therapy for acute myeloid
leukemia (AML) or myelodysplastic syndrome (MDS). Donor-derived alloreactive T cells can kill
recipient leukemia cells, mediating the graft-vs-leukemia effect (GVL). GVL failure leads to post-
transplant relapse, affecting 30-40% of alloSCT recipients and leading to extremely poor
prognosis, with a median survival of 6 months. The clinical sensitivity of leukemias to GVL
varies by disease type. Dr. Shlomchik, Co-PI, sought the mechanism of GVL resistance using
preclinical GVL models and discovered that myeloblastic leukemia required the expression of
the IFN-γ receptor for GVL. Two independent groups reported lower levels of human leukocyte
antigen (HLA) expression in myeloid blasts post-transplant relapse, which IFN-γ can restore in
vitro. These data supported conducting a phase 1 trial to evaluate the safety of IFN-γ
(ACTIMMUNE®) in AML/MDS patients with post-transplant relapse (NCT04628338). 4 out of 6
patients who received IFN-γ and subsequent donor leukocyte infusion (DLI) achieved durable
complete remissions with full donor hematopoiesis recovery. Given these favorable results, we
propose a multicenter phase 2 trial to evaluate the efficacy of IFN-γ/DLI compared to the
outcomes in a synthetic control generated from the Center for International Blood and Marrow
Transplant Research (CIBMTR) database. Patients with AML/MDS who developed relapse with
>5% bone marrow myeloblasts after an HLA-matched alloSCT will be eligible. Subjects will
receive 100mcg of IFN-γ thrice weekly by self-subcutaneous injection for four weeks. If IFN-γ is
tolerated, subjects will receive DLI concurrently with IFN-γ for eight more weeks to complete the
12-week treatment intervention. The primary objective is to evaluate the efficacy of IFN-γ/DLI,
measured by event-free survival at 1 year. The secondary objectives are to evaluate the safety
and efficacy of IFN-γ/DLI measured by secondary endpoints, including measurable disease-
negative complete remission at 6 months and overall survival at 12 months. The incidence of
steroid and ruxolitinib-refractory graft-versus-host disease will be used for the stopping rule. 45
participants will be enrolled to receive IFN-γ/DLI. The major clinical endpoints will be compared
to 3 CIBMTR synthetic cohorts of patients treated with 1) chemotherapy only, 2) chemotherapy+
DLI, or 3) DLI only. Each control group will have 135 subjects (1:3 ratio of treated subjects). In
exploratory studies, we will analyze IFN-γ induced transcriptomic changes in leukemic and
immune cells to find the biomarkers that could be used to select subjects for future studies.

Public health relevance
Project Narrative We propose a novel immunotherapeutic approach to bolster the graft-versus-leukemia effect, addressing the urgent need for effective therapies for post-transplant relapse. In a multicenter phase 2 trial, we will evaluate the efficacy and safety of interferon-gamma and donor leukocyte infusion for patients with acute myeloid leukemia and myelodysplastic syndrome who have relapsed after allogeneic stem cell transplantation. The success of this trial could potentially, for the first time, establish a standard of care for patients with post-transplant relapse.